Role of Notch signaling during the early priming and activation of alloreactive T cells

PROJECT SUMMARY
Graft-versus-host-disease (GVHD) is the most serious complication of allogeneic bone marrow
transplantation (allo-BMT). GVHD pathogenesis is mediated by alloreactive T cells present in the graft that
recognize alloantigens and damage host tissues. Most GVHD therapies rely on global immunosuppression and
are associated with increased risks of infection and decreased graft-versus-tumor effects. New strategies for
GVHD prevention that protect host tissues while simultaneously preserving the tumor-killing activity of
alloimmune T cells are needed. Our laboratory identified Notch signaling and Delta-like1/4 (Dll1/Dll4) Notch
ligands as critical regulators of the pathogenic allo-T cell response, and attractive new therapeutic targets. In
both mouse and non-human primate models, Notch inhibition in donor T cells leads to long-term protection
from GVHD morbidity and mortality. Short-term in vivo Notch blockade using monoclonal antibodies against
specific Notch receptors or ligands blunts the pathogenicity of alloreactive effector T cells without eliciting
broad immunosuppression, reducing GVT activity, or triggering toxic side effects of chronic Notch inhibition.
While a single injection of anti-Dll1/Dll4 Notch ligand antibodies at the time of transplant was sufficient for long-
term GVHD control, Dll1/Dll4 blockade administered >48 hours after transplant provided no protection against
GVHD. Thus, an early pulse of Notch signaling during the initial stages of T cell activation is critical for
establishing a pathogenic T cell state. However, we do not currently understand how short-term Notch
inhibition exerts long-lasting GVHD protection. Alloreactive T cells rely on two central functions to mediate
disease: trafficking to peripheral target organs and producing proinflammatory cytokines. Our preliminary data
show that Notch inhibition preserves initial T cell IL-2 production and expansion in secondary lymphoid organs
while impairing secretion of multiple inflammatory cytokines and homing to the gastrointestinal tract. Therefore,
I hypothesize that Notch signals delivered to allo-T cells during early stages of T cell priming and activation are
critical for trafficking to the gut and initiating a sustained inflammatory cytokine response. I speculate that these
two key mechanisms explain why short-term Notch inhibition prevents many of the severe, pathological
consequences of GVHD. To explore this hypothesis, I will use MHC-mismatched models of GVHD to
investigate how Notch inhibition influences allo-T cell gut tropism. Moreover, I will use a combination of RNA
sequencing, Assay for Transposase-Accessible Chromatin sequencing (ATAC-seq), and Cleave Under
Targets and Release using Nuclease (CUT&RUN) chromatin profiling to provide a genome-wide view of the
transcriptional and epigenetic effects of Notch signaling during early stages of allo-T cell priming/activation.
Altogether, this proposal will elucidate the cellular and molecular mechanisms that underlie the impact of early
Notch signals in shaping the alloimmune response after allo-BMT.

Public health relevance
PROJECT NARRATIVE Notch is a highly conserved signaling pathway that plays an essential role in regulating the damaging immune responses that mediate graft-versus-host disease, a serious complication of allogeneic bone marrow transplantation. The goal of this project is to understand the molecular mechanisms by which short-term Notch inhibition after transplantation leads to durable protection from graft-versus-host disease. Our work will provide essential information about functions of the Notch pathway in the immune system and pave the way towards new treatment strategies of Notch inhibition for patients with graft-versus-host disease and other immune- mediated disorders.